Impact of the implementation of differential privacy to decennial census data in understanding of health disparities in the United States

Summary
The implementation of new differential-avoidance methods, based on differential privacy algorithms, to the 2020 U.S.
Census data and additional data products may affect the usefulness of these data, the accuracy of estimates and rates derived
from them, and critical knowledge about social phenomena such as health disparities. The U.S. Census has released a series
of demonstration products that allow comparisons between the counts produced under traditional and the proposed privacy
algorithm. We test the ramifications of differential privacy by studying changes in the county-level age-specific mortality
rates (ASMRs) for the overall population and racial/ethnic groups. We ask how changes in the denominators, due to the
implementation of differential privacy, result in different ASMRs. We further propose the examination of trends by
comparing the conclusions derived from 2000-2010 comparisons of ASMRs using mortality rates produced using both sets
of denominators. Further, we propose quantifying the changes produced by the implementation of differential privacy in the
empirical associations derived from regression models. We address these aims by examining mortality rates produced using
different vintages of the 2010 decennial counts produced using differential privacy and comparing them with those produced
using the traditional methods. These findings will highlight the consequences of implementing differential privacy for
research examining changes in rates produced by artificial population composition changes. Overall, we will demonstrate
the challenges of using the data products derived from the proposed disclosure avoidance method while highlighting critical
instances where scientific understandings may be negatively impacted.

Public health relevance
Narrative The decennial census is the primary source of statistical information about the population of the U.S., and the quality of its data is of great interest to numerous stakeholders. One particular concern is the accuracy of these data products in light of proposed disclosure avoidance methodologies, primarily if these disproportionately affect scientific understandings of contemporary health disparities. The negative consequences of implementing the proposed privacy algorithm in our knowledge of health disparities underscore the relevance of the proposed research to public health.